Defining novel susceptibility mechanisms to low virulence Toxoplasma gondii strains using the Collaborative Cross and parasite genetics

PROJECT SUMMARY
Toxoplasma gondii is a widespread intracellular parasite of warm-blooded animals and causative agent of
human toxoplasmosis. Mus musculus is an important intermediate host that is possibly entangled in an
evolutionary arms race with this apicomplexan parasite. Our current work using forward genetics to understand
mechanisms of resistance to T. gondii suggests that susceptibility to primary infection is genetically
determined. In this grant submission, we propose to leverage a high diversity recombinant inbred mouse panel,
the Collaborative Cross (CC), as well as parasite genetics to dissect mechanisms that determine disease
outcome following primary infection. Our preliminary data predicts that novel alleles segregating within the CC
panel will determine host susceptibility to previously described `less virulent' strains of T. gondii. However,
virulence is relative and determined by the combined genetics of parasite and host, but which genes and host
responses drive disease severity are not fully understood. We hypothesize that novel host-parasite
interactions govern disease outcome following Toxoplasma gondii infection in Mus musculus
castaneus and musculus murine subspecies. Approaches from genetics, molecular parasitology and
immunology will be utilized to evaluate these hypotheses. In Aim 1, we propose to use the entire CC panel to
genetically map and identify host susceptibility genes to parasite infection with a `low virulent' strain of T.
gondii. In Aim 2, we will leverage our unpublished data to interrogate a parasite locus associated with host
morbidity following primary infection in non-laboratory mice. Whether a genetic conflict occurs between host
and parasite genes identified in this proposal will be examined. With the overarching goal of preventing human
toxoplasmosis, insights gained from this proposal will guide future research on host-parasite relationships and
the genetic basis of parasitic disease.

Public health relevance
PROJECT NARRATIVE Parasites inflict great morbidity worldwide, and there is great need to understand what regulates disease progression. Here we will explore a large panel of genetically diverse mice and parasite strains to test why certain hosts are susceptible to the widespread parasite of mammals, Toxoplasma gondii. This will allow us to discover novel immune genes and parasite effectors that determine disease outcome.